Developing and Validating a Novel Tau Toxicity Model in the Budding Yeast

PROJECT SUMMARY
Many forms of human dementia are caused by aberrantly folded proteins and protein aggregates.
Overexpressing these disease proteins, such as α-synuclein and TBD-43, in the budding yeast Saccharomyces
cerevisiae, also causes cytotoxicity, allowing unbiased powerful genetic screens for modifiers that enhance or
repress toxicity. Hence, this single-celled eukaryotic model has been a powerful genetic tool for discovering
molecular pathways regulating human dementia caused by protein misfolding and aggregation, such as the
Parkinson’s disease and frontotemporal dementia.
Neurofibrillary tangles (NFTs) composed of hyperphosphorylated and aggregated Tau proteins are a
major pathological hallmark of Alzheimer’s disease (AD), as well as other neurodegenerative disorders
collectively termed Tauopathies. Despite the strong clinical association, how wildtype human Tau proteins
become hyperphosphorylated and cytotoxic remains poorly understood. Distinguished from other protein
aggregates that cause dementia, overexpressing human Tau is well tolerated in the budding yeast with no
apparent growth phenotype, even though human tau proteins are also hyperphosphorylated and aggregated in
yeast cells. Hence, no yeast genetic screen for Tau toxicity modifiers has been performed thus far. Yet,
tremendous potential remains if Tau-induced cytotoxicity can be reproduced in the simple yeast model,
permitting unbiased screens to uncover the molecular pathways involved in tau toxicity and related diseases.
In a preliminary screen, we have identified several ORF deletion mutations that show toxicity when human
wildtype Tau (2N4R) is expressed. Interestingly, two of these mutant genes, THP1 and SAC3, encoding for
subunits of the evolutionarily conserved TREX2 complex, are involved in activating stress response gene
expression and mRNA export. Hence, we hypothesize that timely stress response at the transcription level
is necessary for yeast cells to antagonize the toxicity induced by misfolded Tau. It is also possible that
Tau proteins in thp1∆ and sac3∆ mutants adopt a cytotoxic conformation/state reminiscent of the situation of
Tau pathology in neurons. Indeed, our analysis of the NIAGADS database uncovered that AD-associated genetic
variants were found in four of the five subunits of the human TREX2 complex, making it one of the top 15 protein
complexes enriched for AD variants.
For this small pilot project, we will 1) investigate the cause of Tau toxicity in strains mutated for TREX2
subunits using a combination of genetics, genomics and biochemical approaches; 2) develop a set of tools that
can help establish a novel Tau toxicity model in the budding yeast, allowing future unbiased screens for genetic
modifiers of Tau toxicity.

Public health relevance
PROJECT NARRATIVE Neurofibrillary tangles composed of hyperphosphorylated and aggregated Tau protein are a major pathological hallmark of Alzheimer’s disease. Despite the strong clinical association, how wildtype human Tau proteins become hyperphosphorylated and cytotoxic remains poorly understood. This project will investigate the role of mRNA export complex TREX2 in detoxification of human Tau overexpression in the budding yeast Saccharomyces cerevisiae and establish a novel Tau cytotoxicity model in this simple model organism, which will serve as a platform for unbiased genetic suppressor screen for Tau cytotoxicity.